Biosynthesis and Synthetic Biology of Antibiotic Oligosaccharides

PROJECT SUMMARY
Orthosomycins are a family of potent antibiotic oligosaccharides that target a wide spectrum of gram-positive
bacteria, including most antibiotic-resistant strains. It is less appreciated that subsets of orthosomycins also
target gram-negative drug-resistant bacteria, including members of the Enterobacteriaceae family, which are
ranked as some of the highest threats to human health by the Centers for Disease Control and Prevention.
Orthosomycins demonstrate high potency, good bioavailability, and low toxicity in vivo in both animals and
humans. The promise of this class was explored preclinically, and through subsequent development of one
orthosomycin, everninomicin A (Ziracin). Despite Ziracin’s advancement to phase III clinical trials, unstated
pharmacological complications led to a strategic decision to discontinue clinical development of this scaffold in
2000. In the intervening time, no attempts have been made to improve the orthosomycins. We speculate that
addressing pharmacological liabilities was complicated due to the unknown reasons for withdrawal, the
fragmentary understanding of the everninomicin molecular target, and the challenges inherent in orthosomycin
chemical synthesis, which requires at least 130 steps.
Recently, the structures of orthosomycins bound in the bacterial ribosome have been solved, revolutionizing
our understanding of their molecular target and mechanism of action and creating opportunities to improve
ribosome interactions and pharmacological properties via targeted structural changes. Contemporaneously, we
developed a set of genetic tools for editing the genome of the producing organisms, as well as advanced the
understanding of the biochemical mechanisms and pathways of orthosomycin assembly. We have initiated, but
not completed, an exploration of the formation of the interglycosidic orthoester linkages, the formation and
attachment of dichloroisoeverninic acid, and the biosynthesis of the eurekanate sugar, unique to orthosomycin
antibiotics. This convergence of progress in the understanding of orthosomycin biosynthesis and target
identification provides an unprecedented opportunity to address the complications limiting the clinical utility of
these molecules by improving their potency and pharmacological properties. To further this goal, our specific
aims are to (1) characterize and tune the interactions of orthosomycins with rProtein uL16, (2) investigate h89
and h91 spanning interactions of orthosomycins, and (3) develop access to unnatural orthosomycin analogs with
targeted structural changes impacting the rRNA h91 pocket.
Premise: In this project, we outline probable origins and solutions to pharmacological liabilities. Leveraging
biosynthetic insights, we will generate targeted changes in the scaffolds of orthosomycins using a combined
genetic, chemical, and biochemical approach. With these designed variants, we will determine the extent to
which structural variations can improve ribosome binding, as well as modify pharmacological properties to
remove liabilities and improve the therapeutic index.

Public health relevance
Project Narrative. Despite continuous chemical elaboration of the major antibiotic structural scaffolds, pathogenic bacteria have developed resistance to most known antibiotics used in the clinic. Herein we propose to harness a natural product antibiotic scaffold that has never been clinically exploited, the orthosomycins. We propose to develop and systematically apply an amalgam of genetic, chemical, and biological tools to generate new orthosomycins, gain new understanding of their novel mechanism of action, and overcome barriers to clinical application for treatment of multiple drug resistant bacterial infections.